ADJUSTMENT TO BREAST CANCER AMONG YOUNGER WOMEN

This research concerns quality of life among younger women (premenopausal) diagnosed with, and treated for, early stage breast cancer. There is evidence that breast cancer leads to more distress among younger than older patients, and many possible reasons have been suggested for this difference. Study 1 (descriptive study) will examine this issue, assessing the levels of concerns expressed by younger breast cancer patients with regard to a range of issues suggested by various sources as important. We will also assess factors that we view as vulnerability/resilience variables (personality qualities of optimism and investment in body image as a source of self-esteem, contextual qualities of social support/social integration), to determine how the latter variables render individuals vulnerable to higher levels of various concerns. Finally, we will assess mediating variables (coping, perceptions of partner reactions to the surgery) and levels of quality of life (affective, social, and psychosexual disturbance) to determine the extent to which the concerns reported are linked to the distress and dysfunction that are the ultimate outcomes of interest, and to examine the role of coping differences as pathways in this chain. We will also collect open-ended data to ensure that we have identified all meaningful sources of concern among these patients. Subjects will be equivalently represented on extent of surgery (mastectomy vs lumpectomy), and 3 periods of time since surgery (3, 6, and 12 months). We will also recruit as close to equal numbers as we can from the 3 ethnic groups represented in large numbers in this population (Black, non-Hispanic White, and Hispanic). Study 2 (in a new sample) will implement and test the effectiveness of an intervention designed to meet the special needs and concerns of younger breast cancer patients. This intervention is based on findings from the literature of breast cancer, on previous intervention studies of breast cancer patients, on the experiences of this research team in intervention research using other populations, and on the results of Study 1. The once-a-week, 10-week intervention will target participants' sense of confidence about remaining cancer free, their coping responses (increasing acceptance and reframing of the experience, and decreasing avoidance coping), their utilization of social support, and their self- image, in a group-therapy format. The control group will be an education/standard of care group, in which subjects learn of the benefits of implementing some of the changes as described above in their orientation, but will not undergo the group experience in solidifying and acting on this information. Treatment efficacy will be assessed at 3, 6, and 12 months post-surgery, in terms of all the quality-of-life outcome variables listed above. This study will also have the benefit of addressing the generality of the treatment effects across ethnic/cultural boundaries.